DOSE OF INHALED CORTICOSTEROIDS W/ EQUISYSTEMIC EFFECTS (DICE)

The project seeks to define the dose-systemic effects of relationship of beclomethasone (BDP) and fluticasone (FP) using adrenal suppression (cortisol levels) as the primary outcome indicator. The study seeks to obtain preliminary datas on variability of systemic absorption of inhaled corticosteroids among subjects with MILD-MODERATE asthma.